Modernization of Sterilization Equipment in the UK Todd Vivarium

Project Summary/Abstract:
The conduct of quality biomedical research is dependent upon the availability of rodents that are free of several
important diseases. Thus, the cage wash facility of a vivarium is essential for ensuring the prevention of both
cross-contamination of sensitive animal models and outbreaks of opportunistic infections in immune-deficient
strains. This proposal requests a modern, eco-friendly, dry heat sterilizer, which will substantially enhance the
operations of the university’s Division of Laboratory Animal Resources, specifically the research-supporting
functions that advance facility operations to accommodate a rapidly expanding biomedical research enterprise
through enhanced throughput, increased capacity for housing sensitive rodent models, improved biosecurity
for animal colonies, and innovative green technologies for savings in energy and water. Completed for
occupancy in February 2010, the Lee T. Todd, Jr. animal facility was designed to provide a daily inventory of
up to 2,000 sterile mouse cages with appropriate autoclave capacity to meet this demand out of a total 11,000
IVC cages. The initial sterile cage capacity was sufficient to maintain rodents in a rigorously defined microflora
status following rederivation as well as to support immune deficient mouse models, however the increasing
number of researchers and mice in the West Research Complex is outstripping this capacity. Since the Todd
Building’s opening, dry heat sterilizers have begun to be used more frequently in animal facilities instead of
traditional bulk autoclaves for sterilizing rodent cages, bedding, and feed, presenting a unique opportunity to
explore more innovative solutions. These more-modern sterilizers have less-complex technology, resulting in
considerably fewer maintenance requirements; lower initial project costs to deploy; lower operational costs;
and lower infrastructure costs. Smaller, less demanding autoclaves can be used for sterilization of other items
(e.g water bottles) to maximize the higher efficiency of the dry heat units. In order for UK’s researchers to
realize these advantages, the aim of this proposal is to modernize the sterilization equipment within the Todd
Building animal facility by installing a Gruenberg Steri-Dry dry heat sterilizer and a smaller autoclave.
Modernizing the current cage sterilization system in this facility will allow the UK’s researchers to continue
fostering cutting-edge discovery and innovation. Notably, the new equipment will provide much needed
infrastructure to support, improve, and expand the research of UK’s National Cancer Institute-designated
Comprehensive Cancer Care Center, NIH-funded Centers of Biomedical Research Excellence (COBRE), and
numerous additional NIH-funded programs and investigators. In addition, the modernization of this cage wash
equipment is a critical component of UK’s Research Strategic Plan to enhance NIH-funded biomedical
research and support health focused research programs that benefit both Kentuckians and populations beyond
the Commonwealth of Kentucky.

Public health relevance
Project Narrative Research in the Todd Building main vivarium is concentrated in the areas of cancer, metabolic diseases, Alzheimer's disease, and neurologic disease. The cage wash facility of a vivarium is essential in ensuring the prevention of both cross-contamination of sensitive animal models and outbreaks of opportunistic infections in immune-deficient strains. By obtaining a modern, eco- friendly, dry heat sterilizer, we would be ensuring that we are providing a controlled, and consistent microenvironment to support meaningful animal research.